A Family-Genetic Study of Autism and Fragile X Syndrome

Abstract
Fragile X syndrome (FXS) is associated with an increased risk of autism spectrum disorder (ASD), with
prevalence rates ranging from ~40-74%1-6, suggesting that the FMR1 gene (the gene causing FXS) and its
protein product, the Fragile X Mental Retardation Protein (FMRP), constitute a highly important risk for ASD
symptomatology. Importantly, ASD-related features (i.e., the broad autism phenotype, or BAP) have also been
observed at elevated rates among carriers of the FMR1 premutation (PM carriers), providing further evidence
of the role of FMR1-related variation in ASD-related phenotypes. In the original period of funding, this project
identified a number of clinical, psycholinguistic, and social-cognitive features that may serve as candidate
endophenotypes (i.e., heritable traits associated with a disease and measurable in affected and unaffected
individuals) overlapping in ASD and FXS, which were also evident among first-degree relatives at increased
genetic liability (and in the case of FXS, PM carriers). In this revised renewal application, we build on these
promising findings with deep behavioral and neural phenotyping in the domain of pragmatic language (where
we have demonstrated robust overlap in profiles in ASD and FMR1 mutations (PM carriers and FXS). In
particular, we apply multi-method assessments of prosody (e.g., intonation, stress, and rhythm of language),
which is a critical pragmatic skill that is impaired in ASD (and linked with social impairments), and also
impacted in the BAP in unaffected relatives. Analyses include data from three independent cohorts with
extensive existing data available for computational and data-driven analyses to identify phenotypically-defined
homogeneous subgroups that may cross diagnostic borders and provide clues to biological mechanisms that
can inform studies of etiology and treatment. Preliminary data suggest that these pragmatic and prosodic
profiles are associated with the neural processing of speech sounds, with robust differences in the neural
frequency following response (FFR). The FFR is a precise neural index of spectral and temporal encoding of
sound within the midbrain, that serves as a barometer of rapid auditory processing that is linked to expressive
and receptive speech and language-related skills throughout the lifespan7-13. FMRP is highly expressed in the
auditory midbrain, making our focus on the spectral and temporal encoding of speech within the midbrain a
particularly strong candidate as a neural marker linked with FMR1, and relevant to the pathogenesis of
language-related features in ASD. In this renewal application, we investigate the FFR together with a multi-
context assessment of prosody in PM carriers (leveraging data from three independent cohorts and applying
sophisticated computational modeling of prosody across different conversational contexts) to detect key ASD-
related pragmatic and neural phenotypes linked with FMR1-related variation that have significant potential to
illuminate the pathogenesis of ASD and inform treatment.

Public health relevance
Project Narrative This project builds on three extremely rich existing phenotypic datasets from individuals with the FMR1 premutation and their children with FXS, and parallel data collected from ASD families, to identify key pragmatic and prosodic, neural, and molecular-genetic markers in individuals with the premutation and FXS. This study will investigate whether there may be specific pragmatic/prosodic and neural signatures associated with ASD-risk in these individuals, which can be linked to the FMR1 gene. This research takes an important step toward pinpointing different neurobiological and molecular-genetic factors associated with ASD-specific features, and for understanding gene-brain-behavior links to develop targeted interventions.